RESEARCH TRAINING IN SKELETAL DISORDERS

The long term objective of the University of Iowa Research Training Program in Skeletal Disorders is to improve treatment of musculoskeletal injuries and diseases including fractures, joint injuries, arthritis and skeletal deformities by increasing the number of investigators who will advance understanding of the musculoskeletal system. The specific aims include attracting talented postdoctoral trainees with either M.D. or Ph.D. degrees to careers in musculoskeletal research, stimulating them to investigate clinically important musculoskeletal problems, providing them with high quality research education that will prepare them to be productive investigators and promoting collaborative research among M.D. and Ph.D. scientists with different areas of expertise. During their research training program the individuals selected for this program will learn specific research skills, design and perform research projects, and apply their research skills to advance understanding of clinical problems of the musculoskeletal system. Trainees will first develop detailed research protocols with the assistance of a senior investigator. The protocols will then be reviewed by a committee consisting of Joseph Buckwalter, M.D., Richard Brand, M.D., Thomas Brown, Ph.D. and Reginald Cooper, M.D. Following this review the protocol will be refined and the individual will proceed with their research program with guidance from a senior investigator for one to three years. They will work in one of the four Orthopaedic departmental laboratories (i.e., the biomechanics laboratory, the cell and molecular biology laboratory, the morphology and ultrastructure laboratory or the bone healing laboratory). Trainees may also spend part of their time in a laboratory in another department within the University, or less frequently travel to a laboratory at another institution to learn a specific research technique. The emphasis is placed on trainees learning to develop and conduct their own research programs so that at the end of their training program they are prepared to function as productive independent investigators and to collaborate with other scientists. The senior investigator and the Departmental Research Committee will monitor the trainee's progress to ensure that at the completion of training they will have the skills and knowledge to pursue independent investigations of the highest quality that will have significant impact on important clinical problems of the musculoskeletal system.